Small-Molecule Penetration and Efflux in Gram-Negative Bacteria

PROJECT SUMMARY
Small-Molecule Penetration and Efflux in Gram-Negative Bacteria
Gram-negative bacterial infections are increasing in incidence and novel antibiotics are urgently needed to
combat this growing threat to public health. These pathogens have high intrinsic resistance to antibiotics due
to their combination of a two-membrane cell envelope, which presents a permeability barrier to small
molecules, and prevalent efflux pumps, which eject molecules that have successfully penetrated the barrier. A
major obstacle to the development of novel antibiotics is our poor understanding of the structural features of
small molecules that correlate with penetration and efflux across this barrier. As a result, large screening
campaigns of existing discovery libraries have mostly failed to provide new antibacterials. Similarly, while
potent biochemical inhibitors can often be identified for new targets, converting them into compounds with
whole-cell antibacterial activity has proven challenging.
To address this critical problem, we have developed a comprehensive experimental and computational
platform to evaluate and model Small-molecule Penetration and Efflux in Antibiotic-Resistant Gram-Negative
bacteria (SPEAR-GN, “speargun”). We have established all of the key enabling technologies required and
strong proof of concept for the effectiveness of this platform. We will now use our platform to assemble the
larger datasets required to train robust machine learning models of penetration and efflux that will be of broad
utility in antibacterial drug discovery. Herein, we will design and synthesize chemical libraries to map bacterial
penetration and efflux space, analyze compound accumulation in Escherichia coli, Pseudomonas aeruginosa,
and Acinetobacter baumannii using isogenic strain sets that decouple outer-membrane penetration from efflux,
evaluate the role of the BamA outer membrane protein in facilitated permeation of antibiotics, develop machine
learning models based on the assay data to predict compound accumulation, and use the models to design
and synthesize new molecules with improved accumulation in Gram-negative bacteria. Success in this project
will provide a major advance in the field of antibacterial drug discovery to address this major public health
threat.
This project will be carried out by an established multidisciplinary team with a proven track record in this field
and extensive combined expertise in library synthesis and medicinal chemistry, biochemistry and microbiology,
high-throughput assays and mass spectrometry, cheminformatics and machine learning, and antibacterial drug
discovery.

Public health relevance
PUBLIC HEALTH RELEVANCE Small-Molecule Penetration and Efflux in Gram-Negative Bacteria Infections by Gram-negative bacteria pose a growing threat to public health in the U.S. and globally, due to the intrinsic resistance of these pathogens to many antibiotics. A major obstacle to the development of new antibiotics to combat these infections is our poor understanding of the structural requirements for small- molecule drugs to penetrate the Gram-negative cell envelope barrier and to avoid expulsion by efflux pumps. This multidisciplinary project will address this problem by using a comprehensive experimental and computational platform to analyze, model, and predict small-molecule penetration and efflux in three Gram- negative pathogens, thus enabling the development of new Gram-negative antibiotics.